MFB: Fluidics system for efficient site-specific labeling of RNAs

PPROJECT SUMMARY (See instructions):
mRNA in cells contains base modifications, strategically (and dynamically) placed at specific position in
the RNA. For fundamental research, RNA containing site-specific modifications can be generated by
chemical synthesis, but only at very short lengths. The proposed research aims to build on recent
advances in co-immobilized flow transcription to develop an enzymatic system to incorporate (multiple
and different) modified bases site-specifically. Such a system would enable more detailed studies of
translation and alternative splicing, for example, where base modifications are known to play key roles.
Synthesis of RNA with position-specific substitutions will also facilitate studies of RNA structure and
dynamics, where fluorescent probes for FRET/environment studies or stable isotopes for NMR
measurements are essential. A better understanding of the roles of specific base modifications will
ultimately inform future RNA therapeutics.

Public health relevance
RELEVANCE (See instructions): mRNA in cells contains base modifications, strategically (and dynamically) placed at specific position in the RNA. The proposed research will develop a novel system to generate RNA with (multiple and different) modified bases incorporated site-specifically. This capability will allow new studies to dramatically expand our understanding of base modifications in specific genes throughout biology.